Integrating Stochasticity into Biomolecular Mechanisms: A New Direction for Biomolecular Modeling

Integrating Stochasticity into Biomolecular Mechanisms: A New Direction for
Biomolecular Modeling
Abstract
It is increasingly apparent that kinetic selection plays an important role in biology. However, we are just beginning
to have the tools necessary to quantify, characterize and understand it. For biomolecular processes involving
multiple rare-event transitions, the canonical assumption is that mechanisms proceed following a consistent
order of transitions (following a single-pathway). However, increasing evidence from single molecule
experiments and biophysical measurements suggests that multiple pathways are not only possible, but essential.
The goal of the proposed research is to develop an experimentally-directed stochastic simulation
framework for mapping out mechanistic heterogeneity. As applications, I will focus, first, on secondary
active transport in the ClC Cl-/H+ antiporter and ATP hydrolysis driven translocation in several AAA+
ATPases, two processes involving chemical reactions and thus requiring multiscale methods that bridge
the quantum to classical realms.
The proposed approach to multiscale kinetic modeling is focused on multistep biomolecular transformations,
which makes it unique to many other domains of established kinetic modeling. Thus, new methods will be
developed and best practices from other domains will be adapted. It combines a bottom-up calculation of rate
coefficients for kinetically relevant transitions from multiscale simulations, with a top-down parameter refinement
based on experimental data. Innovation is proposed to refine the kinetic solution space with Bayesian parameter
estimation, global sensitivity analysis, uncertainty quantification, reaction path analysis and machine learning
methods. These methods will be used to better characterize the Cl-/H+ exchange mechanism in the ClC-ec1
antiporter in collaboration with Merritt Maduke (Stanford). The kinetic landscape for the wildtype system will be
studied to address the role of pathway heterogeneity, the origin of the non-integral 2.2:1 Cl-:H+ stoichiometry,
and the relevance of the alternating access mechanism.
Similar to secondary active transport, ATP-driven processes inherently involve multiple rate-influencing steps
(ATP binding, hydrolysis, Pi release, ADP release, and all of the associated conformational changes). A
multiscale reactive molecular dynamics method will be developed to describe ATP hydrolysis. Additionally,
enhanced free energy sampling will be used to characterize other transitions and multiscale kinetic models will
be developed to probe the role of kinetic selectivity and to test the controversial stochastic versus sequential
proposed mechanisms in AAA+ ATPases in collaboration with Chris Hill (University of Utah).

Public health relevance
Integrating Stochasticity into Biomolecular Mechanisms: A New Direction for Biomolecular Modeling Narrative It is increasingly apparent that kinetic selection plays an important role in biology. However, we are just beginning to have the tools necessary to quantify, characterize and understand it. The proposed research aims to develop an experimentally-directed simulation framework for mapping out kinetic landscapes and mechanistic heterogeneity to understand the role of kinetic selection in biomolecular processes.